Molecular pathoepidemiology of contralateral breast cancer

ABSTRACT
Survivors of first primary breast cancer (BC) have a 2- to 5-fold increased risk of developing a second
primary in the opposite breast. The high incidence and improved survival for BC has resulted in increasing
numbers (currently nearly 3 million in U.S.) of women at risk of contralateral breast cancer (CBC). Studies to
date have identified environmental, genetic, and treatment-related risk factors for CBC. However, despite
advances in characterizing the etiology of CBC, a large fraction of CBC incidence remains unexplained,
hindering the development of effective risk stratification or risk prediction tools which will be pivotal in
developing effective CBC prevention, surveillance, and therapeutic strategies for BC survivors.
In the context of CBC risk, first primary tumors reflect the joint effects of environmental exposures and
host features, including those that are known and measurable as well as those that are unidentified and/or
unmeasurable. Molecular features of first primary tumors could be powerful complementary indicators of risk of
CBC. In a strategy designed to advance risk stratification capacity, we will use cutting edge genomic
technologies to interrogate first primary tumors in the context of CBC risk. We will also assess the concordance
of molecular features in paired first and second primary tumors to elucidate insights into the biology of CBC
and potentially shared etiologic mechanisms.
The proposed research builds on the unique resources of the large multi-center WECARE Study of
CBC with features including: population-based ascertainment of CBC cases and controls (women with
unilateral breast cancer (UBC)); detailed clinical data including treatment of first primary BCs from medical
record reviews; extensive risk factor data; germline genetic data from an ongoing GWAS; and mammographic
density data. We will obtain tumor blocks for first primary breast tumors of >500 UBC controls and first primary
tumors plus contralateral tumors from > 500 CBC cases. Laboratory work will include: pathology reviews;
transcriptome-wide molecular profiling of tumors; IHC analyses; and replication analyses.
Our Primary Aim is to identify molecular biomarkers in first primary breast tumors associated with risk
of developing a subsequent CBC. We will conduct: RNA-sequencing on first primary tumors; identify the most
informative markers; develop a molecular signature associated with CBC and evaluate it jointly with treatment
and lifestyle/personal/medical/germline genetic risk factors; and replicate with similar risk factors in an
independent sample of > 400 CBC cases and > 400 UBC controls. Our Secondary Aims are to: (1) examine
the risk signature in first primary tumors (established in the Primary Aim) in relation to CBC subtype-specific
risk; and (2) assess the concordance of gene/transcript expression or alterations and subtypes in paired first
primary and contralateral tumors and determine the extent to which lifestyle/personal/medical/germline genetic
risk factors and treatment affect the development of marker-concordant CBC.

Public health relevance
PROJECT NARRATIVE There are nearly three million current breast cancer (BC) survivors in the U.S., and these women face a high risk of developing a second primary cancer in the opposite or contralateral breast (CBC). There is an urgent need for tools that can identify women at higher (and lower) risk of CBC. Biomarkers in the first primary tumor of BC cases likely relate to risk of CBC, and their identification could be a powerful step toward an effective CBC risk prediction approach. The primary goal of the proposed research is therefore to identify molecular profiles in first primary BCs that are associated with risk of CBC in a large, well-characterized population. We propose a novel study that is of clinical importance to the many women who survive their first primary breast cancer.